Multidisciplinary Virtual Care for Young Adults with Type 1 Diabetes Living in Rural Areas

PROJECT ABSTRACT
Candidate: Dr. Daniel Tilden MD, MPH is an endocrinologist and rural health services researcher at the
University of Kansas Medical Center (KUMC) uniquely qualified to conduct the proposed project, having
completed both pediatric and adult endocrinology fellowships and clinical care activities including rural
outreach and pediatric-to-adult transfer acceptance clinics. His research focuses on developing health system
interventions to improve outcomes for young adults (YAs) with type 1 diabetes (T1D) living in rural areas. Dr.
Tilden’s long-term goal is to become a leader in the development and implementation of clinical interventions
to improve outcomes for YAs with T1D in rural areas. His combination of clinical expertise, research skills in
quantitative and qualitative methods, a strong mentorship team, and unique institutional resources make him
ideally suited, with the support of this award, to become a successful independent early career researcher.
Research Project: People with T1D living in rural areas have lower rates of diabetes device use and lack
access to guideline-directed multidisciplinary care. Among people with T1D, YAs (age 18 to 30) are a
particularly high-risk group as they navigate both the complexities of obtaining adequate health care and the
social, educational and economic challenges of this developmental stage. Efforts to address these care gaps,
such as Project ECHO-Diabetes, while effective in delivering care in areas with strong PCP availability, fall
short in more rural settings where PCP availability and referral networks are sparse. This proposal seeks to
build on preliminary quantitative and qualitative data to examine provider-identified barriers, facilitators and
solutions to guideline-driven care (Aim 1). We will then pilot test the Rural Emerging/Young Adult
CollaboraTive care – T1D (REACT-T1D) program which builds on Project ECHO-Diabetes to partner with
PCPs in the virtual delivery of direct diabetes care to YAs with T1D living in rural areas (Aim 2). Finally, we will
apply implementation science frameworks to develop strategies to support testing of this model in a future fully
powered, R01 funded randomized trial to test the REACT-T1D intervention.
Career Development: Dr. Tilden has assembled a multidisciplinary group of content and methodological
experts and didactic experiences to help him acquire the skills needed to achieve his research aims and
launch his career as an independent investigator. His career development plan integrates coursework,
experiential learning and direct mentorship from content experts to: 1) Develop skills in using implementation
science methods to design, plan, and test novel interventions; 2) Become an expert in rural recruitment and
study execution 3) Hone qualitative methods expertise to support program evaluation; 4) Develop practical
skills in pragmatic trial planning, design and execution; and 5) Strengthen skills for grant development,
manuscript writing and leadership of research teams.

Public health relevance
PROJECT NARRATIVE Young adults with type 1 diabetes living in rural areas are a group particularly vulnerable to poor outcomes, with higher hemoglobin A1c levels and lower use of diabetes technology such as continuous glucose monitors. Current resources available to rural primary care providers fall short in providing the multidisciplinary care required for optimal outcomes in this population. Therefore, building on Project ECHO-Diabetes, we will pilot test the Rural Emerging/Young Adult CollaboraTive care – Type 1 Diabetes program to determine the feasibility and acceptability of this intervention and provide preliminary data for a future fully-powered hybrid randomized trial to test the implementation and effectiveness of the program to address existing inequities in access to care.